Multisensory interventions to improve neurodevelopmental outcomes of preterm infants hospitalized in the neonatal intensive care unit

Project Summary
The long-term goal of this project is to improve the health and well-being of preterm infants and their parents.
Very preterm infants necessitate medical care in the neonatal intensive care unit (NICU) at birth and can be
hospitalized for their first several months of life, where they are exposed to repetitive, painful stimuli, are
separated from their parents, and often do not receive positive, timed sensory exposures that are similar to
what they would have received if not born early. In addition, parents often do not know when and how to
engage with their infant in the NICU. However, early positive sensory experiences are important, as they
enhance brain development during an important period of time and can be used as a tool to help parents
participate during NICU hospitalization and establish early parent-child relationships to optimize development.
Although there is evidence to support positive multisensory interventions in the NICU, these interventions are
often applied in an inconsistent manner, reducing their benefit. Through a rigorous and scientific process, we
have developed a structured multisensory intervention program, titled Supporting and Enhancing NICU
Sensory Experiences (SENSE), which includes specific doses and targeted timing of evidence-based
interventions such as massage, auditory exposure, rocking, holding, and skin-to-skin care. The interventions
are based on the infant’s developmental stage and are adapted based on the infant’s medical status and
behavioral cues. The multisensory interventions are designed to be conducted during each day of NICU
hospitalization by the parents, who are educated and supported to provide them. A sensory support team fills
in gaps when parents are unable to reach the targeted amount of sensory exposures each day. The proposed
work aims to determine the effect of multisensory interventions on parent mental health, parent-child
interaction, brain activity (amplitude integrated electroencephalography), and infant developmental outcomes
through age 2 years, with specific attention to language outcome. Two-hundred fifteen parent-infant dyads of
preterm infants born ≤ 32 weeks gestation and admitted to a Level IV NICU will be enrolled within 1 week of
birth. Infants will be randomized to either the SENSE multisensory program or to the standard of care during
the NICU stay. The SENSE program combines structured, easy-to-conduct, multisensory interventions with
parent engagement to optimize outcomes in the complex medical environment of the NICU. Standardized
assessments of parent mental health, infant neurodevelopment, and parent-child interaction will be conducted
prior to NICU discharge and at 6 months, 1 year, and 2 years, adjusted for prematurity. Differences between
groups will be investigated. Brain activity during NICU stay, including in the presence and absence of different
sensory exposures, will also be investigated. The expected outcome is that the SENSE multisensory program
will have a positive effect on improving outcomes. Importantly, the SENSE program has been implemented
with ease in >250 hospitals in the US and abroad, so there is great potential for broad and long-term impact.

Public health relevance
Project Narrative There is evidence to support positive multisensory exposures in the NICU (such as skin-to-skin, holding, and language exposure), but these interventions are not applied in a consistent manner, reducing their benefit to high-risk infants. The critical next step is to address knowledge gaps about the effects of daily, evidence- based, positive, and multisensory interventions provided to very preterm infants throughout the duration of NICU hospitalization, on brain development during an important period of time. This is important to public health as it impacts millions of infants and families worldwide, the NICU environment is a modifiable factor, and there is high demand for interventions that can change the experience of NICU hospitalization, improve early parent-child relationships, and optimize developmental outcomes.